The impact of poly-substance use on the crosstalk between microglia, astrocytes, and neurons that regulates HIV latency

Background. This proposal entitled “The impact of poly-substance use on the crosstalk between microglia,
astrocytes, and neurons that regulates HIV latency" is submitted in response to RFA-DA-24-001: Ex Vivo
Models for Studies at the Intersection of HIV and Poly-Substance Use”. Although combination antiretroviral
therapy (ART) dramatically lowers the levels of HIV RNA in the brain, it does not reduce the prevalence of HIV-
associated neurocognitive disorders (HAND), which still develops in up to 50% of people with HIV (PWH). Poly-
substance use in PWH increases the risk of developing HAND, creating a significant unmet medical challenge.
Our goal. Our proposed ex vivo studies of poly-substance exposure are based on newly developed methods to
derive authentic microglia, astrocytes, and neurons from induced pluripotent stem cells (iPSC). We will study the
responses of these cells to HIV and poly-substance exposure in mono-, di-, tri-cultures, and organoids. Our
previous work has shown that HIV latency is established due to signals from healthy neurons and astrocytes that
drive infected microglia into a homeostatic state. The latent virus becomes reactivated in response to
inflammatory cytokines and neuronal damage. For example, adding methamphetamine (METH) at a
physiologically relevant concentration (100 nM) to co-cultures of microglia and neurons induces HIV reactivation
and neuronal damage. Also, it sensitizes HIV-infected microglia to reactivation by inflammatory stimuli such as
TNF-α. We will test the hypothesis that poly-substance use (combinations of methamphetamine and opioids)
deregulates the cortical/dopaminergic system and disrupts the homeostatic regulation of microglia, leading to
HIV reactivation and increased neuronal damage. In addition to measuring the impact of poly-substance
exposure on HIV reactivation, we will use single-cell RNA sequencing to study the changes in cellular signaling
and activation induced by substance exposure.
How will we advance the field? To define how intracellular signaling between neurons, astrocytes, and
microglia is dysregulated by poly-substance exposure, we will first investigate how METH and opioids affect the
expression of crucial signal/receptor pairs (CD200/CD200R, CX3XL1/CX3CR1, glucocorticoid/GR, DA/DRD1-5)
in the presence or absence of HIV. In addition, since we discovered unexpectedly that adenosine is a potent
silencer of HIV in iMG cells, we will investigate how extracellular ATP produced by neurotoxicity and astrocyte
activation is metabolized to adenosine by surface receptors on microglial cells and promotes HIV silencing.
Understanding these mechanisms at the molecular level will set the stage for devising effective anti-inflammatory
strategies to ameliorate HAND in the context of poly-substance use.
challenging studies because it is only by working within the context of
We are undertaking these technically
authentic human microglial cells in an
environment that better reflects the HIV-infected CNS that the underlying physiology is accurately represented.

Public health relevance
Project Narrative Poly-substance use (METH, opioids) has been shown to enhance neuronal damage and dramatically increase the risk of HIV-associated neurocognitive disorders (HAND), creating a significant unmet medical challenge. Here we will use ex vivo models derived from induced pluripotent stem cells (iPSC) to determine whether silent HIV infections in the brain become reactivated in response to poly-substance exposure and dissect the intracellular signals responsible for HIV reactivation.